Targeting evolving therapy resistance

PROJECT 1 SUMMARY/ABSTRACT
Neuroblastoma (NB) remains a leading cause of childhood cancer deaths, and the patients who do survive are
left with long-term side effects, many of which can be life threatening. While the paradigm of molecularly targeted
therapies holds great promise, genomic studies have revealed that NBs are characterized by extensive
intratumor genetic heterogeneity, with subclonal oncogenic drivers often selected for during standard
chemoradiotherapy. Our broad hypothesis is that NB therapy resistance is a dynamic and evolving phenomenon
that can be serially monitored and rationally treated with targeted small molecules and immunotherapies. Our
group discovered gain-of-function mutations in the ALK receptor tyrosine kinase as the etiology for familial NB,
and at the same time co-discovered with several other groups identical mutations as the most frequent somatic
single nucleotide variants leading to a potent oncogenic driver in up to 25% of newly diagnosed high-risk cases.
We have shown that activating mutations in the ALK-RAS-MAPK pathway are highly enriched in the relapse NB
genome, providing the impetus for deep and comprehensive characterization of the spatial and temporal
heterogeneity underpinning therapy resistance across the continuum of therapy. More recently, we have
uncovered epigenetic mechanisms of initial chemotherapy resistance with single cell technologies. Finally, our
recent discovery of methods to target non-mutated peptides derived from intracellular oncoproteins with cellular
therapies offers a new class of therapeutics to target key molecular drivers of NB cellular persistence. The work
proposed in this renewal application will address the challenges of intra-tumoral heterogeneity and persistent
NB cells that survive therapy and constitute a major cause of treatment failure. We will test our central hypothesis
with three Specific Aims: 1) Identify clonal and subclonal mutations in ctDNA and their evolution during therapy;
2) Develop therapies for patients with ATRX mutant/ALT-driven indolent NB; and 3) Discover therapeutically
targetable mechanisms of NB cellular persistence. We will leverage circulating tumor DNA and single cell RNA
and ATAC sequencing technologies, as well as paradigm-shifting recent advancements in developing chimeric
antigen receptors that precisely target peptides presented on the major histocompatibility complex that have the
potential to vastly expand the pool of immunotherapeutic targets and broaden the population of patients who
would benefit from such therapy. In parallel, we will develop EZH2 inhibition therapy in combination with
immunotherapy for patients with indolent NB, and develop new therapies targeting the NF-κB and other pathways
mediating NB cellular persistence. We consider this project significant because it will result in new mechanism-
based biomarker-defined therapeutic strategies that ultimately should significantly improve high-risk NB patient
outcomes. This will address the major unmet need that despite unprecedented discoveries in defining the basic
mechanisms of NB tumorigenesis, this knowledge has not yet translated into significantly improved outcomes
for patients with high-risk disease.

Public health relevance
NARRATIVE Project 1 is relevant to public health because it seeks to discover the fundamental reasons why cancer becomes resistant to therapy by understanding solid tumor cellular heterogeneity and adaptation to modern therapies, within a Program focused on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational evidence-based therapeutic strategies to reduce the health burden of high-risk neuroblastoma, and perhaps other human cancers.